Antiretroviral mechanisms of TRIM56

PROJECT SUMMARY/ABSTRACT
The innate immune effector TRIM56 restricts a broad range of viruses, yet its molecular mechanisms
remain elusive. I propose to uncover the underlying mechanism of TRIM56’s antiviral activity, with a
focus on HIV-1, where its role is better understood. TRIM56 is an E3 ubiquitin ligase, which typically
mediates the transfer of ubiquitin to a target substrate with potential impacts on stability, binding, or
trafficking of the target protein. Unlike most E3 ligases, which utilize protein-interaction domains for
substrate recognition, TRIM56 utilizes an NHL domain known for its RNA binding activity. This unique
feature suggests that TRIM56 may employ an unconventional mode of target recognition, possibly
involving direct interaction with viral RNA.
My preliminary data reveal that TRIM56 interacts with the HIV-1 genome similarly to the viral
packaging protein Gag, and that the ubiquitin ligase function of TRIM56 is important for restricting
HIV-1. While these data do not directly demonstrate whether TRIM56 NHL binds RNA directly or
indirectly, they support the two following hypotheses: (a) TRIM56 may directly bind the HIV-1 RNA,
thereby blocking Gag binding and subsequent viral packaging, while ubiquitinating nearby proteins
co-occupying the RNA to limit viral RNA stability or translation; (b) TRIM56 may bind HIV-1 RNA
indirectly through Gag, and subsequently ubiquitinate Gag to promote its degradation. To distinguish
between these hypotheses, I will (I) investigate the mode of viral genomic RNA recognition (whether
direct or indirect) using biochemistry and structural biology; (II) determine the ubiquitination target of
TRIM56 using proteomic analyses and viral translation and packaging assays. The proposed
research promises to identify a novel mechanism for viral RNA detection and restriction. It will also lay
the groundwork for further exploration of TRIM56’s actions against other viruses, with the ultimate
goal to identify a unifying mechanism for broad viral sensing.
I will carry out this research in the laboratory of Dr. Sun Hur at Boston Children’s Hospital
(BCH)/Harvard Medical School (HMS). Dr. Hur is an expert on innate immune response to pathogen
nucleic acids, and her lab additionally hosts expertise in protein biochemistry and structural biology.
The BCH/HMS environment supports postdoctoral research fellows with numerous core facilities,
technique trainings, and career development workshops, in addition to supporting a rich intellectual
environment in which many labs collaborate. I will leverage the surrounding expertise, research
seminars, and professional development courses during the fellowship period to strengthen my
research and to prepare to independently head a lab.

Public health relevance
PROJECT NARRATIVE Our innate immune system is responsible for detecting and responding to pathogens, distinct from our own molecular signatures. The proposed research will elucidate one broadly antiviral protein’s mechanism of action against HIV-1. Results from this study will provide new context to understand a little-studied class of innate immune receptors that both detect and directly act against viruses and may lay the groundwork for future antiviral therapeutics.